Targeting cross-linked amyloid protein species as a therapy for AD.

[unreadable] DESCRIPTION (provided by applicant): Excessive accumulation of Ab protein in b-amyloid deposits is a hallmark event in Alzheimer's disease (AD). In recent years, some of the most promising therapeutic strategies for potentiating b-amyloid clearance has involved the use of anti-Ab antibodies. In transgenic animal models of AD b-amyloid deposition can be inhibited by either peripheral infusion of exogenous anti-Ab antibodies (passive) or autoimmunity induced by immunization with synthetic Ab peptide (active). Unfortunately, the latter approach has been associated with potentially fatal complications involving inflammation of the CNS vasculature in humans. While experiments to date have employed unmodified monomeric Ab to test for autoimmunity, up to 40 % of the Ab pool in AD brain consists of low molecular weight oligomeric cross-linked b-amyloid protein species (CAPS). Moreover, numerous lines of evidence have implicated soluble CAPS as the primary neurotoxic agent in AD. We have recently reported that while levels of autoantibodies to monomeric Ab are similar in the plasma of AD and non-demented control subjects, autoantibodies to CAPS are significantly reduced in AD patients. In addition, age-at-onset for AD correlates with plasma immunoreactivity to CAPS. Based on these findings, we hypothesize that the sub-pool of Ab autoantibodies targeted at CAPS may normally provide a natural defense against AD pathogenesis, but are depleted in AD patients. Accordingly, replenishing the level of anti-CAPS antibodies could potentially provide therapeutic benefit for AD. In the proposed study we plan to a) identify CAPS with the highest neurotoxic potential, b) select single-chain fragment variable antibodies (scFvs) specific for the most neurotoxic CAPS using recombinant phage display system to identify CAPS-specific immunoreactive scFvs from a vector library of over 10^12 human derived antibodies, and, c) test anti-CAPS scFv antibodies for activity in attenuating CAPS neurotoxicity in primary cultures of cortical neurons. We posit that targeting soluble CAPS with human derived antibodies may have distinct advantages over previous vaccine-based AD treatment strategies that have employed more generic anti-Ab antibodies. Finally, with regard to passive immunization therapies, by specifically targeting the Ab species that are most relevant to AD pathology, lower anti-Ab antibody titers might be prescribed, thereby attenuating potential side-effects associated with inflammation. [unreadable] [unreadable] [unreadable]